Comprehensive Resource for the Drosophila 4th chromosome

The 4th chromosome is the final frontier for genetic analysis in Drosophila. Small and devoid of recombination
the 4th has long been ignored. Nevertheless, it contains 79 protein coding genes. 92% of the protein coding
genes have human counterparts and 68% of these human genes have a disease association. We propose to
renew our project to build a Comprehensive Resource for the Drosophila 4th Chromosome. The project is highly
visible in the community. It is known as the Fourth Chromosome Resource Project (FCRP) at the Bloomington
and Kyoto stock centers as well as in the FlyBase and FlyPush databases. After three years of funding, the
FCRP has 446 stocks publicly available and is on track to exceed the proposed goal by 15%. To date, four
papers are published and 311 stocks were ordered from Bloomington in 2022. Evidence of impact is that FCRP
stocks constitute 0.3% of the Bloomington stock center, but FCRP shipments supported 13% of the NIH grants
funding stock orders from Bloomington in 2022. Further evidence of impact is that FCRP stocks for the five most
popular 4th genes were ordered at a rate matching the top 3% of all Bloomington stocks. Three of the stock sets
have gone well: 1) the UAS.fly cDNA stocks, 2) the UAS.human homolog cDNA stocks and 3) the conversion of
MiMIC transgenes to gene trap and protein trap stocks. However, during the project we noted several unmet
needs. We propose to address these by continuing to build the two sets that remain incomplete, adding a
UAS.RNAi set, plus conducting validation and phenotyping studies on all FCRP stocks. The Specific Aim remains
to generate a comprehensive resource enabling modern genetic analysis for protein coding genes on the
Drosophila 4th chromosome. One set that will continue is to mutagenize every 4th gene individually on our
FRT101F chromosome for loss of function studies and marked single cell clones. The second continuing set is
UAS.human cDNA stocks for the top two human relatives of each conserved 4th gene. The need to add a set of
UAS.RNAi stocks for genes on the 4th was noted by the PI of the fly Transgenic RNAi Project. Their set of 4th
UAS.RNAi stocks is incomplete and the FCRP was encouraged to finish the job. The need for confidence in our
stocks will be met with experimental validation. The need to provide investigators with a starting point for genetic
analyses will be met by phenotyping. Our systematic observations of phenotypes such as mutant lethality or
sterility plus transcript expression and protein localization are the first data for the 58% of 4th genes that were
never studied before. Validation of gene trap null mutants and their UAS.fly cDNAs in rescue experiments sets
the stage for humanized stocks. When null mutations are rescued by UAS.human cDNAs subsequent mating of
rescued flies creates a humanized stock. These stocks provide opportunities to apply Drosophila genetics to the
analysis of human gene interactions and function. Taken together, FCRP stocks will facilitate all manner of
biochemical, genetic and molecular studies. The resource is readily available to enhance our understanding of
conserved molecular mechanisms underlying human health and disease.

Public health relevance
PUBLIC PURPOSE We propose to renew a collaborative project that will advance our understanding of human health and disease. We will utilize new innovative strategies to expand an existing research resource for scientists. Validation experiments in our labs employing strains from our resource have shed new light on basic biological mechanisms such as gene regulation and alternative splicing as well as provided new avenues for the analysis of human health and disease.